Structures, light signaling and allostery mechanisms of photoreceptor kinases

Project Summary
Photoreceptor kinases are multi-domain signaling proteins that regulate a wide range of light responses in
living organisms. They share similar modular protein architecture with many receptor kinases involved in
virulence detection, and cell metabolism, migration, and differentiation. Despite their importance in signal
transduction and disease biology, how receptor kinases couple a molecular trigger such as light absorption or
ligand binding to a phosphorylation signal remains elusive at both the structural and mechanistic levels. The
primary challenge is that these signaling proteins are intrinsically dynamic, largely limiting structural studies
to their truncated forms. However, a complete mechanistic understanding requires structural and functional
interrogation of full-length proteins in which both sensor and effector domains are present. To address these
challenges, we will harness recent advances in cryo-EM single particle analysis to investigate the structures
and dynamics of full-length photoreceptor kinases that share key mechanistic aspects with their prokaryotic
and eukaryotic counterparts. Our long-term goal is to elucidate the general principles of signaling and
allosteric regulation in modular receptor kinases by provoking and resolving functionally relevant structure
dynamics. Building on our expertise in photoreceptor research, we will take an integrated approach of
structural biology, biochemistry, and spectroscopy to tackle the molecular mechanisms of light-dependent
kinase activation in two representative bilin-based photoreceptors - a canonical bacteriophytochrome and a
dual-sensor photoreceptor kinase. Our supporting data have revealed light-induced global protein
reorganizations in both systems, demonstrating the feasibility of these studies. In this project, we will first
determine the full-length structures in different signaling states by resolving structural heterogeneity. We will
then establish the functional relevance of the resolved structures by comparing their population change
between datasets obtained under different light and ligand conditions. We will also dissect the motions in the
central helical spine while addressing the roles of dimer asymmetry and order-disorder transition in long-
range signaling via a joint analysis of conformational states captured by cryoEM and crystallography. Last but
not the least, we will employ complementary methods of mutagenesis and functional assays to interrogate key
interactions underlying the allosteric regulation and signal integration. Findings from the proposed studies
will provide unprecedented insights into the molecular events driving the allosteric actions in modular
receptor kinases beyond photoreceptors. Bilin-based photoreceptors are photo-switchable, spectrally versatile,
and modular in function. They hold great promise in diverse biomedical applications exploiting light to probe
cellular processes, modulate biological functions, and treat human diseases. Importantly, the mechanistic
understanding gained from these naturally occurring photoreceptors will lay the foundation for ultimately
engineering light-activated enzymes of desired signaling logic in novel therapeutic solutions via optogenetics.

Public health relevance
Project Narrative Understanding how receptor kinases achieve allosteric regulation at the molecular level is of fundamental importance for disease biology and drug discovery. This project will tackle the structural basis and molecular mechanism of allosteric signaling in two photoreceptor kinases using advanced biophysical methods. Insights gained from these studies are expected to reveal the general principles of protein allostery, and thus lay the groundwork for developing optogenetic tools and new therapeutic strategies to treat human diseases.